Adolescent Alcohol Abuse, PTSD and Alzheimer's Disease Administrative Supplement

PROJECT SUMMARY/ABSTRACT
Anxiety and depression co-occur in both alcohol use disorder (AUD) and Alzheimer’s disease, and both illnesses
target the noradrenergic system and circuits in hippocampus and amygdala. This overlap in symptoms and
impacted brain regions raise the question of shared mechanisms, and whether adolescent intermittent ethanol
exposure can set the brain on a trajectory that makes it more susceptible to Alzheimer’s pathology and related
dementia in aging. Conflicting literature shows light to moderate alcohol drinking may be protective, while others
report increased risk, or no effect, of alcohol use and AD risk. Variable durations and intensity of alcohol use and
measures of dementia likely contribute to the lack of a coherent understanding of the interactions of alcohol
exposure and development of Alzheimer’s disease. Use of preclinical models and well controlled studies will
provide a platform to understand possible overlapping mechanisms that can trigger AD following significant
ethanol exposure during adolescence. Surprisingly, to date, extremely few preclinical studies have investigated
the interaction between alcohol use and AD risk and disease progression. In support of the hypothesis that AUD
augments AD pathology, a recent study using adolescent intermittent ethanol exposure (P25-55) in 3xFAD mice
harboring three human AD mutations displayed increased Aβ1–42 accumulation in hippocampus, amygdala, and
entorhinal cortex and pTau accumulation in hippocampus of adult females. These mice also experienced
increased anxiety and learning and memory deficits. Importantly, pharmacologically blocking inflammation
prevented both the pathological and behavioral changes. In another study in humanize pTau mutant mice,
intermittent ethanol increased excitability of locus coeruleus (LC) noradrenergic neurons with a greatest effect
in females. Our expertise in AUD, AD, sex differences and synaptic circuits skillfully and uniquely positions us to
test the overarching hypothesis that adolescent intermittent ethanol accelerates AD pathology and synaptic
dysfunction and shortens the period of prodromal AD. Aim 1 will test the hypothesis that AIE exposure
accelerates accumulation of Ab and pTau and increases gliosis and neuronal and synaptic dysfunction during
prodromal AD in adult TgF344-AD rats. Aim 2 will test the hypothesis that AIE exposure accelerates deficits in
learning and memory, increases anxiety, and impaires fear extinction during the prodromal phase of AD in adult
TgF344-AD rats. These studies will provide foundational information regarding the interaction of AUD and AD
and the findings will serve as a launch pad for future mechanistic studies.

Public health relevance
8. PROJECT NARRATIVE Alcohol use disorder induces brain inflammation and targets the same brain circuits damaged by Ab and pTau in Alzheimer’s disease. We will determine if adolescent intermittent ethanol exposure accelerates AD pathology during early disease progression. The findings will reveal an important interplay between alcohol use and AD.